Development of an Accurate, Long and Fast DNA Synthesis Device

ABSTRACT
In recent years the need for long custom synthetic DNA has rapidly increased. While chemical synthesis of
oligonucleotides of up to 100 base pairs is a relatively simple and established process, chemical synthesis of
longer oligonucleotides is inefficient and costly, resulting in a product with high accumulated errors and limited
yield. Current approaches to making long DNAs instead generate shorter overlapping DNA oligos and
biochemically assemble them to create the desired DNA sequence. In addition to being confounded by issues
of secondary structure and repetitive sequences, these methods are laborious, time-consuming and relatively
expensive.
This project proposes the development of a DNA synthesizer capable of manufacturing DNA oligonucleotides of
over two-thousand base pairs. The synthesizer will be a semiconductor-based device, about the size of a USB
thumb-drive, and will employ enzyme-catalyzed DNA synthesis. After loading the device with a few microliters
of reagent, DNA will be synthesized at the single molecule level in a nano reactor cell (NRC). A high-fidelity DNA
amplification will be used to generate larger quantities of DNA post synthesis. Iridia has developed a novel
biochemistry for the DNA synthesis based on an engineered topoisomerase, and have shown this biochemistry
to be compatible with solid-state nanopores in a semiconductor chip. The key innovation concepts are: (1) the
reagents in the NRC are segregated by nanopores, such that only DNA (and not enzymes) can move through
the nanopores, allowing electrophoretic control of the sequential reactions; (2) the NRC enzyme loading process,
wherein activated enzymes charged with DNA bases are introduced through the appropriate microfluidic
channels; and (3) engineering of a secondary DNA structure which can be observed via monitoring of the
nanopore current, enabling real time quality control of the synthesis reaction.
The first phase of this project will focus on optimizing and characterizing the biochemistry of the platform. The
second phase will be aimed to integrate the biochemistry into a semiconductor-based nanopore device to enable
single molecule DNA synthesis with real-time monitoring. A high-fidelity amplification approach will then be used
to generate larger quantities of DNA for the user. Iridia, Inc. expect this approach to enable synthesis of DNA of
several thousand nucleotides with a very low error rate.

Public health relevance
NARRATIVE An enzyme-catalyzed DNA synthesizer capable of manufacturing DNA oligonucleotides exceeding two-thousand bases will be built, applying innovative molecular biology advancements to address the challenges and high cost of long DNA synthesis. This DNA synthesizer will vastly improve the speed of DNA synthesis, increase by at least an order of magnitude the length of DNA strands that can be made, as well as radically increase the accuracy of the resulting synthetic DNA molecules as compared to current technologies.